Major Histocompatibility Complex Shapes Early Life Microbial Events to prevent Autoimmunity

Project Summary:
Type 1 diabetes (T1D) is a debilitating autoimmune disease that affects millions. Unfortunately, the
incidence of T1D is rising. The strongest genetic factor in T1D is the MHC class II locus. Some MHC haplotypes
are associated with higher risk to T1D, while others provide dominant protection. Yet, the mechanism remains
unknown. Recent studies suggest that environmental factors, such as the microbiome, also contribute to the
increasing incidence of T1D. While both genetic and environmental factors contribute to the risk of developing
T1D, little is known of how MHC II genetic factors interact with microbial factors. The non-obese diabetic (NOD)
murine model recapitulates many features of T1D in humans including the dominant protection associated with
the MHC class II locus. NOD mice spontaneously develop T1D, but autoimmunity can be prevented by transgenic
expression of the MHCII E allele (Eα16/NOD mice). Recent published studies and new preliminary data from
our laboratory suggests that microbiota are critical for this protection. The goal of this proposal is to identify
immunomodulatory bacteria and immune system pathways that can be used to develop preventative T1D
therapies for genetically at-risk patients
To rigorously study the early-life microbiota, we developed a novel consortium of 9 culturable bacteria
(which we call PedsCom) that represent over 90% of the bacteria in pre-weaning diabetes-protected Eα16/NOD
mice. To investigate immunomodulatory mechanisms of specific bacteria, we are applying gnotobiotic techniques
using the PedsCom consortium and genetic models of disease utilizing Eα16/NOD mice. The experiments
outlined in this proposal will elucidate the mechanisms by which MHC II molecules interact with intestinal
microbes to prevent T1D. In Aim 1, I will investigate if MHC II E expression impacts early-life events to shape
microbial colonization by comparing colonization dynamics and humoral responses to commensal bacteria in
the NOD and Eα16/NOD mice colonized by the PedsCom consortia. In Aim 2, I will determine if the PedsCom
consortia of early-life microbes are sufficient to prevent T1D and whether peripheral regulatory T cells prevent
T1D in Eα16/NOD mice by studying PedsCom, specific pathogen free (SPF), and germ-free colonized mice.
During this fellowship, these investigations will expand my technical skills, improve my aptitude for
experimental design and analysis, and enhance my ability to communicate findings to the scientific community.
I will complete this fellowship at the University of Pennsylvania, which offers programs, courses, and structured
mentorships that will aid my career development. In addition, I will take advantage of opportunities offered by
the Immunology Graduate Group and the Medical Scientist Training Program to enhance my abilities as an
educator and a clinician. With the resources available to me, I will explore the fundamental and clinically relevant
questions in this proposal to gain the skills necessary to become a successful physician scientist.

Public health relevance
Project Narrative: The incidence of type 1 diabetes (T1D), an autoimmune disease which affect millions of people worldwide, has been rising for the past half century. While both genetic and environmental factors contribute to the risk of developing T1D, recent studies indicate that early-life microbial interactions with the developing immune system offer a critical window of opportunity to influence the immune system development and prevent disease. Our study uses a new mouse model of the early-life microbiome, derived from a line of mice that are genetically protected from T1D, to identify immunomodulatory commensal bacteria and immune system pathways that can be used to develop effective preventative therapies for T1D.